Dissecting the role of redox homeostasis and ferroptosis in lung cancer

PROJECT SUMMARY
Cancer is a disease of hyperproliferation, and tumor cells increase their metabolic output to support sustained
growth, which can lead to increased oxidative stress that damages macromolecules like lipids. Multiple pre-
clinical and clinical studies have now demonstrated that dietary antioxidants or common cancer mutations that
activate antioxidant pathways can promote tumor growth and metastasis, highlighting the importance of oxidative
homeostasis in tumorigenesis. However, whether oxidative stress accumulates to a point of cell death in tumors
and the in vivo mechanisms of such oxidative stress-dependent cell death remain elusive.
Accumulating evidence indicates that oxidative stress can lead to excessive lipid peroxidation of membrane-
associated fatty acids, resulting in membrane rupture and subsequently a non-apoptotic form of cell death,
termed ferroptosis. Many intracellular mechanisms have been found to regulate lipid peroxidation and ferroptosis,
and there is an emerging body of literature suggesting that cancer cells are highly susceptible to ferroptosis in
vitro. In addition, several conventional cancer therapies, such as chemotherapy and radiation, have been shown
to effectively eliminate cancer cells by promoting lipid peroxidation and inducing ferroptotic death. However,
despite the enthusiasm about ferroptosis and its therapeutic potential in cancer, there are major gaps in our
knowledge that will be addressed by this proposal:
1) Does ferroptosis occur in tumors, and is it a barrier to tumorigenesis?
2) Do common cancer mutations regulate oxidative metabolism to suppress ferroptosis?
Prior studies have been limited by lack of in vivo tractable models to study ferroptosis, but in this fellowship, we
propose a novel preclinical platform to investigate ferroptosis as a bottleneck during tumor progression that can
also be exploited therapeutically (Aim1). Building upon these in vivo models, we will also determine how specific
cancer mutations rewire metabolic programs to sustain tumor growth and whether overcoming ferroptosis is an
underlying mechanism driving disease progression (Aim2).

Public health relevance
PUBLIC HEALTH RELEVANCE STATEMENT (NARRATIVE) Despite improved screening efforts and therapeutic advancements over the past decade, lung cancer continues to be the leading cause of cancer-related deaths worldwide and the second most prevalent cancer type in the United States, presenting an ongoing medical challenge for which scientific investigation can translate into significant clinical benefit. Some cancers, including lung cancer, have been shown to be susceptible to a novel, oxidative-stress dependent form of cell death, termed ferroptosis, so enhancing ferroptosis may be an alternative therapeutic strategy to target tumors that are resistant to conventional therapy. Using cutting-edge, preclinical mouse models that closely mimic human lung cancer, this work will determine if induction of ferroptosis impedes tumor development and investigate how specific common cancer mutations protect against ferroptosis to promote tumor growth, with the goal of providing deeper insight into a novel mechanism of cell death that can be harnessed for future cancer therapies.